Identifying mechanisms ofsynapse maturation at neuronal subtype resolution

Project Summary/Abstract
The human brain function relies on the formation and maintenance of precise neural circuits among more than
100 subtypes of neurons. These circuits are mediated by synapses, the characteristics of which vary depending
on neuronal subtype. Synaptic dysfunction plays a critical role in most, if not all, human brain disorders. Thus,
understanding synaptic diversity and its developmental origin are crucial for us to understand how the brain
functions and how it goes awry in mental disorders. During brain development, synapses undergo profound
changes to become mature and fully functional. Maturation of glutamatergic synapses involves changes in the
postsynaptic density (PSD), a highly sophisticated protein complex composed of >1,000 proteins. However, the
compositional changes of the PSD in development were not well characterized. My preliminary data revealed
the temporal dynamics of >1,000 PSD proteins during cerebral cortex development, providing initial insight into
mechanisms of synapse maturation. Moreover, integrative analysis of the developing PSD proteome and single-
cell RNA-seq data suggested that different neuronal subtypes undergo divergent synapse maturation processes.
However, we know little about the compositional diversity of neuronal subtype-specific synapses or the different
maturation processes they go through. In addition, synapse maturation, diversity, and specificity can be
controlled by transcription, but the underlying gene regulatory programs remain elusive. This information is
particularly relevant to mental disorders like autism spectrum disorder, in which genetic mutations converge on
transcription regulation and synaptic transmission. Thus, the specific aims of this project first seek to uncover
the compositional diversity of neuronal subtype-specific synapses in the developing cerebral cortex using a novel
chemogenetic method (Aim 1, K99 phase). The second aim is to decode the disease-relevant gene regulatory
mechanisms that generate this diversity by applying single-cell genomics and machine learning approaches (Aim
2, K99 phase). Finally, using the training, tools, and preliminary data from the K99 phase of my proposal, I will
launch an independent research project that focuses on investigating the effects of neuronal activity on synapse
maturation and plasticity at neuronal subtype resolution (R00 phase). Results from these studies will provide
insights into synapse diversity, its regulatory mechanisms, and its dysregulation in autism. My long-term goal is
to study the functional importance of synapse diversity on neural circuits and behaviors and develop targeted
therapies to alleviate synaptic dysfunction in mental disorders in patients. Additional training obtained during this
award in developmental neurobiology (with Dr. Arnold Kriegstein), synaptic biology (with Dr. Robert Edwards),
chemogenetics (with Dr. Alice Ting), and advanced machine learning (with Dr. Jingjing Li), combined with my
previous experience in rodent models, proteomics, and single-cell genomics will provide me with a solid
foundation for an independent research career to achieve my goal.

Public health relevance
Project Narrative Our brain function relies on the formation and maintenance of precise neural circuits among various subtypes of neurons, whose disruption contributes to many mental disorders including autism spectrum disorder. Neural circuits are mediated by synapses with distinct characteristics between neuronal subtypes and across developmental stages. Characterizing the diversity of synapses and elucidating the underlying developmental mechanisms will offer perspectives into how circuit specificity is established and how it goes awry in mental disorders.